Microbiome and intestinal barrier in ALS therapy

Background and Innovation: The goal of this renewal Merit Award application is to investigate the
mechanisms of intestinal function and microbiome in Amyotrophic lateral sclerosis (ALS), meanwhile providing
a novel approach through microbiome and metabolites that can potentially treat ALS by restoring gut-neuron-
microbial axis. ALS is a fatal neuromuscular disease characterized by progressive death of motor neurons and
muscle atrophy. Veterans are twice as likely to be diagnosed with ALS as the general population. Microbiome
and intestinal homeostasis play essential roles in neurological diseases. The complex interplay of intestinal -
central nervous system communication involves autonomic and enteric nervous systems, neuroendocrine and
immune systems. However, little is known about the intestinal microbiome in Veterans with ALS. Our lab is the
first to discover the link between intestinal homeostasis and the disease progression in an ALS SOD1G93A mouse
model. Our study in human ALS further reveals the dysbiosis and intestinal inflammation. Reduced bacterial
diversity and reduced butyrate-producing bacteria (dysbiosis) correlate with enteric neuromuscular and central
nervous disorders. Along these lines, we have demonstrated that
had damaged tight junctions, impaired enteric neuromuscular
ALS mice (both SOD1G93A and TDP43 models)
system, and reduced barriers. Remarkably,
restoring the intestinal homeostasis by feeding the ALS model mice with butyrate significantly delayed the
disease onset and prolonged the life span of ALS mice. However, the clinical applications of microbiome and
beneficial microbial metabolites in ALS are in its infancy. There is still a dire need to develop novel treatments
for ALS and improving the life quality of ALS patients. Based on our progress in the VA Merit Award, publications,
and provocative preliminary studies, we hypothesize that targeting the gut-neuron-microbiome axis should
improve the barrier function and restore microbiome, thus slowing disease progression of ALS. We have
designed two Aims to rigorously examine the hypotheses: Aim 1. Determine the mechanisms that contribute to
dysbiosis and barrier dysfunction through gut- microbiome-neuron axis in ALS. We will define the mechanism
for abnormal barriers and dysbiosis using ALS mice and establishing a novel humanized ALS microbiome model.
ALS mice will have fecal microbiota transplantation (FMT) using human microbiome from Veterans with ALS.
We will investigate roles of microbiome, using novel molecular tools, human enteroid cultures, enteric glia cells,
and transgenic models. We will determine mechanisms underlying ALS associated microbiome on intestinal
barrier, blood-brain-barrier (BBB), and neuroprotection through the gut-microbiome-neuron axis in the
pathogenesis of ALS. Aim 2. Identify metabolites for preserving intestinal barrier and neuromuscular function in
ALS. We will use multi-omics to identify beneficial metabolites and perform molecular biological assessments
of intestinal and neuromuscular integrity to evaluate metabolites. We will examine their efficacy of restoring gut-
microbiome-neuron axis in slowing ALS progression using different ALS models.
Innovation of this project lies in its: (a) therapeutic potential for ALS, (b) conceptual frame-work to
discover early changes and dysbiosis and the gut barrier effects before onset of ALS, (c) multi-Omics methods
to identify beneficial microbiome/metabolites, and (d) state-of–the-art experimental models that allow us to
understand mechanisms by restoring gut-neuron-microbial axis in ALS.
Significance and Impact to Veterans Healthcare: Military veterans, regardless of the branch of service,
the era in which they served, or whether they served during a time of peace or war, are at a greater risk of dying
from ALS than if they had not military service. Our study is significant because of the health burden of ALS in
VA population and the novel role of the microbiome on neuromuscular function in health and disease, especially
in Veterans’ care. Path to translation: It has significant translational implications for developing new therapeutic
strategies by restoring gut-neuron-microbial axis for combating ALS and improving the health of Veterans.

Public health relevance
ALS is a fatal neuromuscular disease. Most patients die within 5 years of disease onset. Veterans are twice as likely to be diagnosed with ALS as the general population. Despite intensive research efforts, there is no effective cure for ALS. Therefore, there is a dire need to develop novel and effective approaches to combat ALS. We will investigate the novel mechanism of intestinal dysfunction and dysbiosis in ALS and explore therapeutic targets for ALS by restoring healthy gut-microbiome-neuron axis and intestinal homeostasis. Fulfillment of the studies will bring novel concepts to the ALS research and have significant translational implications for developing new therapeutic strategies for ALS in VA population and improving Veterans’ care. The proposed studies are, therefore, relevant to the VA patients as well as the general patient population.